Genetic ancestry effects on molecular and complex traits in TOPMed

ABSTRACT:
The Trans-Omics for Precision Medicine (TOPMed) project has reached a critical size threshold. Freeze 10
of the TOPMed cohort now includes n=180,852 individuals with high coverage WGS, with over 1.074
BILLION variants characterized. Beyond genomic data, TOPMed also includes n=73,294 individuals with
RNA-seq gene expression data, n=92,659 individuals with metabolomic data, n=85,684 individuals with
methylation data, and n=43,057 individuals with proteomic data. These ‘omics phenotypes enable rich
characterization of the multiple dimensions of biology that are relevant for human disease. Importantly, 60%
of individuals identify as non-White with n>51k of individuals identifying as Black/African American, n>34k
identifying as Hispanic/Latino, and span multiple HLBS phenotypes. We will utilize the TOPMed project data
to address two pressing questions. First, how do race, ethnicity, and genetic ancestry contribute to complex
traits across the continuum of human populations in the US? Second, how do alleles at different frequencies
in different genetic ancestry groups contribute to complex traits? This project will leverage data from whole
genome sequencing (WGS), RNAseq expression, metabolomics, and a bevy of heart, lung, blood, and
sleep disorders to make headway understanding how to keep the continuum of human populations at the
forefront of precision medicine.

Public health relevance
PROJECT NARRATIVE The Trans-Omics for Precision Medicine (TOPMed) project brings together large-scale ‘omics data across heart, lung, blood, and sleep disorders. Our work will address how race, ethnicity, and genetic ancestry all contribute to molecular traits and complex disorders. We will also uncover how the genetic architecture of molecular and complex traits varies across populations.